Changing Oceans Affect Shellfish Toxins

Harmful algal blooms (HABs) of the dinoflagellate Alexandrium spp. threaten coastal populations
of humans and wildlife in Alaska. Toxins produced by Alexandrium can accumulate in shellfish
and other filter feeders and at high concentrations and cause paralytic shellfish poisoning (PSP).
In response to community concerns regarding the safety of shellfish harvest Southeast Alaska
Tribal Ocean Research (SEATOR), a network of coastal tribal communities, created a robust and
expansive monitoring program for HABs, shellfish toxins, and ocean acidification (OA). A major
concern for coastal Alaskan communities is how environmental conditions will affect the safety of
subsistence shellfish harvest. Warming sea surface temperatures, air temperatures, and
increasing acidity have the potential to alter production of toxins by Alexandrium and increase the
potential bloom window into seasons not typically associated with HABs. This uncertainty will be
addressed in this project using a multi-faceted and rigorous approach. Aim 1 will leverage long
term monitoring data from SEATOR (n=3,433 shellfish samples), in situ environmental
measurements, remote sensing products, and traditional ecological knowledge to generate
machine learning and mixed effects harmonic models predicting shellfish toxins from
environmental variables. Congener specific data generated in Project 2 will also be analyzed for
species specific and spatial trends in association with environmental variables. Aim 2 will analyze
919 discrete OA samples collected by coastal communities paired with 1,814 previously analyzed
discrete samples to investigate spatiotemporal relationships between OA parameters (i.e. pCO2)
on shellfish toxin dynamics. Using OA parameters constrained from Aim 2 and environmental
data from Aim 1, Aim 3 will use in vivo experimentation to examine the effects of changing ocean
conditions (temperature, pCO2) on toxin accumulation and maximum toxicity in subsistence
shellfish species. This project creates an important linkage between empirical models of HABs
and shellfish toxicity and environmental conditions, creating outputs of HAB dynamics which are
actionable and will be shared with tribal partners and communities.